Mechanisms of pediatric overweight and obesity underlying susceptibility to multisystem inflammatory syndrome in children (MIS-C)

PROJECT SUMMARY
The proposed studies for this diversity supplement will provide career development and in-depth training in
translational immunology for a talented candidate with a Master’s degree in Cellular and Molecular Pathobiology.
The parent grant for this application investigates the mechanisms by which pediatric overweight and obesity
increase the risk of Multisystem Inflammatory Syndrome in Children (MIS-C), a severe pediatric complication of
SARS-CoV-2 infection. In leading the proposed studies, the candidate will develop expertise in concepts of
inflammatory signaling and in widely applicable methods used to measure human immune cell activation. From
this work, we anticipate that the candidate will publish at least one first-author paper and a present at the national
Clinical Immunology Society meeting in 2023. Mentorship from two successful physician-scientist investigators,
combined with collaborative interactions with the parent grant study team, will provide highly relevant career
development opportunities towards the candidate’s goal of obtaining an MD/PhD at the interface of immunity
and infectious pathogens.

Public health relevance
PROJECT NARRATIVE The need for a more diverse scientific workforce in immunology has been highlighted during the COVID-19 pandemic. This diversity supplement application will support the research training, mentorship, and career development of a talented individual from an underrepresented background poised to begin training as a physician-scientist in translational immunology.